Strategies for Persistent Agitated Delirium in Palliative Care

PROJECT SUMMARY
Delirium is the most common and distressing neuropsychiatric syndrome in cancer patients. It has a negative
effect on symptom assessment, patient-clinician communication, decision making, and survival. Approximately
50% of patients with hyperactive or mixed delirium continue to experience agitation despite low-dose
haloperidol, which can be particularly distressing to patients and caregivers. Neuroleptic dose escalation,
benzodiazepine rotation, combination therapy, and neuroleptic withdrawal may provide good control of
agitation. However, no delirium trials have ever been completed to directly compare these options; such trials
are urgently needed to improve the quality of life of patients with this devastating syndrome.
Our long-term goal is to develop evidence-based therapy for the palliation of delirium in cancer patients.
The proposed study is a high-impact, 4-arm, multi-center, double-blind, double-dummy, randomized controlled
trial to compare the effect of neuroleptic dose escalation, benzodiazepine rotation, combination therapy, and
neuroleptic withdrawal in the treatment of persistent agitated delirium in cancer patients admitted to acute
palliative care units (APCUs). We hypothesize that benzodiazepine rotation and combination therapy are
particularly effective against agitated delirium. The primary specific aim of this study is to compare the effect of
neuroleptic dose escalation, benzodiazepine rotation, combination therapy, and neuroleptic withdrawal on the
change in Richmond Agitation Sedation Scale (RASS) over 24 hours in patients who did not experience a
response to low-dose haloperidol. The second aim is to compare the effects of these treatments on (1) rescue
medication use, (2) the proportion of patients in the target RASS range, (3) perceived comfort by caregivers
and bedside nurses, (4) delirium-related distress in caregivers and nurses, (5) achievement of the proxy
comfort goal, (6) symptom expression, (7) delirium severity, (8) adverse effects, and (9) quality of end-of-life
care. The third aim is to identify novel predictive markers of response to haloperidol and lorazepam. After
obtaining surrogate consent, we will administer the study medications under a titration scheme and monitor the
participants closely until discharge.
This study is highly innovative because (1) multiple previously untested treatment strategies are studied,
(2) the outcome measures (e.g., proxy comfort goals) are novel, (3) biomarkers are included as potential
predictors of treatment response, (4) the patient population (i.e., short survival) is unique, and (5) the study
setting (i.e., the APCU) is distinctive. Successful completion of this definitive study will identify the optimal
strategy to reduce agitation, improve patient comfort, and palliate delirium-related distress; provide timely data
to address the ongoing debate regarding the proper use of haloperidol and lorazepam in delirium; inform novel
strategies to monitor patients with delirium; and stimulate further studies to identify better strategies to palliate
persistent agitation and improve patients' quality of life.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it evaluates novel therapeutic options for which there is strong theoretical and empirical support of their effectiveness against persistent agitated delirium, one of the most common and distressing syndromes in cancer patients at the end-of-life. This project is relevant to the NIH's mission because the effective management of agitated delirium may ultimately help to increase patient comfort and decrease delirium-related distress in patients, caregivers, and healthcare professionals, and a better understanding of how neuroleptics and benzodiazepines affect delirium-related symptoms will help us to devise newer, more effective treatments that improve the quality of life of cancer patients suffering from this devastating syndrome.